Administrative Core

The Principal Investigator (D Livingston) oversees the entire operation of the Program. The chief administrative assistant (Ann Desai) reports to the PI, who provides direction as she carries out her financial and other logistical planning and oversight responsibilities while coordinating among the three institutions involved in the Program (DFCI, HMS, Tufts Med School). The director of our Gene Function Manipulation Core facility (W. Hahn) will also report to the PI on the ongoing operations of that unit.